EPIGENETIC REPROGRAMMING OF T CELL EXHAUSTION TO ENHANCE TUMOR IMMUNOTHERAPY

SUMMARY: Chimeric antigen receptor (CAR) T cell therapy has been shown to be curative for
relapsed/refractory B-ALL; however autologous AML CAR T cells exhibit limited expansion and anti-tumor
response. The myeloid tumor microenvironment is well-established as being immunosuppressive, but recently
our group has reported a subset of myelodysplastic syndrome (MDS) patients with unprecedent response to
immune checkpoint blockade (ICB) therapy. Notably, this striking clinical response to ICB was coupled to
mutation of the epigenetic regulator ASXL1 among the patient’s T cells. We have extended this finding by
validating that deliberate disruption of ASXL1 in murine and human T cells prevents their dysfunction in
suppressive tumor and viral microenvironments. Our preliminary investigation of suppressive factors among the
serum of AML samples revealed elevated levels of the damage-associated molecular patterns (DAMPs)
molecule S100A9 relative to the serum from B-ALL patients. Moreover, S100A9 is able to activate naïve T cells
in the absence of antigen. Based on our published and unpublished work, we hypothesize that DAMPs produced
from suppressive tumor microenvironments imprint terminal differentiation programs among endogenous T cells
used for therapy. Therefore, the aims of our proposal are 1) To investigate DAMP-induced epigenetic
programs during T cell dysfunction. 2) To determine if myeloid-associated immunosuppression
promotes an ASXL1-mediated exhaustion program in CAR T cells. 3) To determine if ASXL1 disruption
protects allogenic CAR T cells from the immunosuppressive microenvironment of AML. The research
proposed here will broadly identify the interactions between innate sensors in a suppressive tumor
microenvironment that result in epigenetic enforcement of endogenous T cell terminal differentiation. These
findings will be applied to test the hypothesis that DAMPs specifically limit the antitumor functions of AML CAR
T cells through an ASXL1 dependent mechanism. The mechanism will be extended to endogenous and CAR T
cell samples collected from patients in an actively enrolling clinical study at St Jude assessing CD123 CAR T
cells for patients with AML. Completion of these studies will not only work toward identifying epigenetic
mechanisms that can be engineered to protect CAR T cells from leukemia-induced dysfunction, but will also
identify predictive biomarkers that will guide CAR T cell manufacturing and clinical assessment.

Public health relevance
NARRATIVE: The work proposed here will identify innate signals in the myeloid tumor microenvironment that promote antigen-independent epigenetic reinforcement of T cell dysfunction. We will test the hypothesis that disruption of ASXL1 and its epigenetic partners, enable resistance to tumor-mediated immunosuppression in CAR T cell model systems and treated patients. Broadly, our investigation of tumor microenvironment mediated T cell suppression will address mechanisms limiting CAR T cell efficacy in clinically-relevant hematological settings and provide a path for developing novel strategies to improve the efficacy of T cell-based immunotherapies.